Development of a Rapid and Non-Contrast Low-Field MRI-Based Assessment of Pulmonary Embolism

The goal of this project is to develop an efficient 3D, contrast-free, low-field Magnetic Resonance Imaging (MRI)
pipeline to detect pulmonary embolism (PE), leveraging the unique physics of low-field MRI and denoising via deep
learning. PE is a major cause of acute cardiovascular mortality worldwide, surpassed only in frequency by myocardial
infarction and stroke. When patients present in the Emergency Department (ED) with PE symptoms, immediate diagnosis
is critical to enable prompt and appropriate treatment. Computed Tomography Pulmonary Angiography (CTPA) is the current
imaging gold standard for PE diagnosis, but its use is limited in settings where exposure to ionizing radiation and the
associated cancer risk is severely undesirable (i.e. for children or pregnant patients). CTPA also requires the injection of
iodinated contrast media which is contraindicated in a significant fraction of the population. Magnetic Resonance Imaging
(MRI) is a radiation-free alternative for diagnostic imaging, although the lungs are traditionally not imaged using MRI due to
poor image quality. However, MRI does not require ionizing radiation, and vascular evaluation often can be performed
without the need for contrast agents. An efficient, simple, contrast-free, whole-lung MRI method for the assessment
of the pulmonary vasculature would enable the detection of PEs without the disadvantages of CT.
Recent advancements in MRI hardware, primarily the availability of FDA-cleared lower-field 0.55T MRI systems, have
revitalized lung MRI as a field of study. The proposed project aims to develop a fast, contrast-free, 3D whole-lung low-
field MRI protocol for PE detection that is both comfortable for the patient and simple to perform:
Aim 1: Develop and optimize a data collection and image reconstruction pipeline for rapid, free-breathing, high-
resolution, contrast-free, 3D whole-lung MRI at 0.55T with high vessel conspicuity for PE detection
We will develop a 3D balanced steady-state free-precession MRI (bSSFP) acquisition which can be used during free-
breathing for whole-lung imaging (covering a field-of-view of approximately 400x400x300mm) with a resolution of 1mm3 in
an acquisition time of less than 10 minutes. Following optimization of the acquisition/reconstruction pipeline, images of the
lung vasculature will be collected in 10 healthy subjects and assessed by three cardiothoracic radiologists for visibility of
first and second-order pulmonary branches and the ability to track vessels and distinguish pulmonary arteries from veins.
Aim 2: Compare the PE detectability of low-field MRI to that of CTPA in a cohort of ED patients
We hypothesize that the low-field, contrast-free 3D whole-lung MRI imaging pipeline developed in Aim 1 will enable PE
detection in the first and second-order pulmonary branches comparable to that of CTPA. A cohort of 40 patients presenting
in the ED with suspicion of PE scheduled to undergo a CTPA scan will be recruited for an additional low-field MRI scan.
Three radiologists will compare the CTPA and MRI images to assess the number of clots, and their location and size; they
will also evaluate diagnostic confidence using a Likert scale.
Outcome: When successful, this project will provide preliminary data showing the potential for rapid, contrast-free lung PE
screening using a low-field MRI technique that is easy to perform in the ED.

Public health relevance
Project Narrative: Pulmonary Embolism (PE) is diagnosed via Computed Tomography (CT), which is contraindicated in a large number of patients, such as those with known allergies to CT contrast agents (0.2-0.7% of the population) and pregnant patients (with an increased risk of PE). In this project, we will design a rapid, 3D contrast-free, low-ﬁeld Magnetic Resonance Imaging (MRI) data collection and reconstruction pipeline to image PE, with a focus on patients presenting in the Emergency Department who cannot undergo CT. The unique advantages of low-ﬁeld MRI over conventional systems will be leveraged, including improved visualization of tissues near the lungs and the potential for citing in Emergency Departments due to the lower costs and space requirements of these systems.